Models of Autoimmune Disease in a Genetically Defined Rabbit Breeding Colony

In a special breeding project with the goal of developing one or more models of autoimmune disease, we bred rabbits within our colony for susceptibility to disease induction. The initial focus of our study was a rabbit model of human Systemic Lupus Erythematosus (SLE). It is known that in man some genes affect susceptibility to several different autoimmune diseases. Thus selective breeding may result in broader susceptibility to autoimmune diseases. SLE is a complex, chronic autoimmune disorder that predominately affects young women. Clinical symptoms may include rash, arthritis, nephritis, and neurological disruption (including cognitive decline, seizures, psychosis). SLE is characterized by the production of autoantibodies to various nuclear antigens and double-stranded DNA (dsDNA). We immunized groups of rabbits with an NMDA glutamate receptor-derived peptide on a multiple antigen peptide backbone (BB) based on reports that some anti-DNA antibodies from mice and from lupus patients cross react with the NR2 glutamate receptor, and extending earlier published reports, we also immunized rabbits with an Sm B/B-prime-derived peptide on BB. Immunization with these two different peptide immunogens led to development of anti-dsDNA antibodies, and other correlates of human SLE. Comparisons of preimmune and post-immunization sera suggest that levels of anti-dsDNA and antinuclear antibodies have increased in some MAP-peptide immunized rabbits. Rabbits from both immunization groups with high anti-dsDNA responses were observed to experience seizures. Our studies confirmed one earlier report that used Sm peptide immunization to induce SLE-like serology in non-pedigreed rabbits, and extended the studies to a new peptide immunogen (Rai et al J.Immunol 176:660-7, 2006,). The use of our unique pedigreed rabbits contributes to understanding the interactions of genetic susceptibility with exposure to defined external immunogens leading to SLE-like manifestations. Studies of two additional groups of relatives and progeny from the first four groups of immunized rabbits were completed. We cloned and sequenced the rabbit homologs of Blys (BAFF) and its receptor BR3 and analyzed BAFF and BR3 mRNA and protein expression in cells and tissues of affected rabbits. Based on the deduced conceptual sequence from our cDNA cloning of the BAFF Receptor protein (BR3), we synthesized a rabbit mini BR3 peptide that binds to rabbit BAFF as has been reported for the homologous stretch of human BR3. We expressed and purified recombinant rabbit BAFF protein (J Yang et al, ms in preparation) that will be used in future AIDS vaccine research.